Effectiveness of a National Health Care Community Partnership to Prevent Diabetes

DESCRIPTION (provided by applicant): Project Abstract Today over 60 million Americans have prediabetes, and it is estimated that almost one quarter of these individuals could develop diabetes within the next 5 to 7 years. The Diabetes Prevention Program (DPP) demonstrated that an intensive lifestyle intervention resulting in modest weight loss and increased physical activity can delay or prevent the development of type 2 diabetes for adults with prediabetes. Unfortunately, the DPP lifestyle intervention was not initially designed for delivery on a public health scale, and the costs and intensity of this intervention have delayed any passive dissemination of this approach since the DPP's results were first released some 9 years ago. However, recent studies by our group at Indiana University have demonstrated that delivery of a group-based adaptation of the DPP lifestyle intervention by trained YMCA employees can achieve weight loss and behavioral changes similar to the DPP but for only about 1/8 the cost. Now, through a new partnership involving UnitedHealth Group (UHG) and the YMCA of USA, efforts are actively underway to scale this model for DPP delivery nationally. In this exciting collaboration, UHG will provide a new administrative service for employer groups and other health purchasers that will help to identify adults with pre-diabetes, reach out to these high risk persons, and assist them in enrolling in the YMCA's group-based DPP intervention program. UHG will then manage a system of value-driven payments to the YMCA, based on levels of participation and weight loss achieved by each high risk person who is enrolled. Although this will not suffice as the only means for addressing the prevention and control of diabetes on a population scale, this new partnership creates an exciting opportunity to evaluate the feasibility and sustainability of a generalizable way for delivering the DPP nationally through efforts that involve a large commercial health payer and a leading community organization. With the strong support of both UnitedHealth Group and the YMCA to provide extensive and ongoing access to several administrative data sources, we propose to evaluate the reach, implementation, costs, effectiveness, and maintenance of these efforts for tens of thousands of high risk adults in multiple regions throughout the U.S. Through a national survey of large employers, we will also collect information regarding incentives and payment for weight management and chronic disease prevention services. Through these efforts, we hope to understand more about the factors that impact reach and effectiveness of this new program as the structure of payment varies across different UHG markets, and we also hope to identify how changes in the delivery model or benefit structure over time might help to enhance reach to more employer groups and to improve participation and weight loss success for more individuals. Should our evaluation find this partnered prevention strategy to be cost- effective and sustainable, these results will be pivotal to the timely dissemination of an important new component of nationwide efforts to prevent type 2 diabetes among over 60 million Americans who already have prediabetes today.

Public health relevance
Project Narrative The proposed research program is designed to evaluate the costs and effectiveness of a naturally emerging partnership involving the YMCA of USA and a large commercial health payer (UnitedHealth Group) to finance, deliver, and reimburse the DPP lifestyle intervention for high risk adults with prediabetes throughout the U.S. Should our proposed evaluation find this partnered approach to be cost- effective and sustainable, the results will be pivotal to inform the timely and efficient dissemination of the DPP lifestyle intervention as an instrumental component of real-world efforts to improve health and prevent disease for over 60 million Americans with prediabetes today. __SpecificAimsTextDelimiter__ A. Specific Aims It is estimated that 1 in 3 Americans born today will develop diabetes in their lifetime.1 Given the profound fiscal, emotional, and social burden of diabetes, this is a future we must attempt to avoid. However, such a goal is likely to require multi-pronged efforts that address cardinal risk factors such as physical inactivity and unhealthy eating on a population scale,2, 3 in addition to more focused and intensive efforts to support behavior changes among persons who are at extremely high risk for developing diabetes today.4 Most person who will develop type 2 diabetes in the future will first progress through a "high risk" state known as prediabetes.5 Today over 60 million Americans have prediabetes, and it is estimated that almost one quarter of these could develop diabetes within the next 5 to 7 years.6 Fortunately, prediabetes can be identified with simple blood tests that are performed every day in health care settings across the U.S. Furthermore, over 580 million primary care visits each year offer opportunities not only to identify prediabetes but also to raise awareness and provide access to an evidence-based prevention program, such as the Diabetes Prevention Program lifestyle intervention, which has been shown to reduce the development of diabetes by more than half.7 Because programs such as the DPP involve moderate increases in physical activity and healthful eating as a means to achieve modest weight loss, they also have cross-cutting benefits, such as improving other cardiovascular risk factors and global health status.8, 9 Unfortunately, the DPP has to date proved too intensive and costly for routine delivery within the health care sector alone.10 In an attempt to help address the growing burden of type 2 diabetes, UnitedHealth Group and the YMCA have partnered in an effort to offer a lower-cost, group-based adaptation of the DPP lifestyle intervention. As part of an innovative new health benefit structure, UHG will provide a new administrative service for employer groups and other health purchasers to help identify adults with pre-diabetes, reach out to these high risk persons, and assist them in enrolling in a group-adaptation of the DPP offered by trained instructors who are employed by the YMCA. In recent randomized effectiveness trials, this same program has demonstrated great promise by delivering the DPP with high fidelity and achieving weight loss levels commensurate with the DPP clinical trial for about 1/8 the cost.11, 12 Although this cannot suffice as the only means for addressing the prevention and control of diabetes on a population scale, this new partnership is an exciting opportunity to evaluate the feasibility and sustainability of a generalizable way for reaching thousands of high risk adults by delivering the DPP nationally through a leading community organizational channel. For the past 7 years our evaluation team has been at the forefront of developing and researching new models to prevent type 2 diabetes via health care-community partnerships. Since June 2009, we have been working closely with leaders at UHG and the YMCA to plan the evaluation of a multi- regional DPP scaling initiative. We now propose the following primary evaluation aims: 1) To evaluate the reach, implementation, costs, and effectiveness of a group-based DPP lifestyle intervention that is delivered by the YMCA, administratively managed by a commercial health care organization, and financed through employer contributions and health plan dollars 2) To determine the current perceptions and practices of large U.S. employers regarding programs and behavioral economic incentives for obesity management and diabetes prevention 3) To explore the effect of different employer-based behavioral economic incentives on participation levels and effectiveness among high risk adults who are offered the YMCA prevention program